Investigating the human spleen as an archive of memory B cells reactive to the influenza virus hemagglutinin

PROJECT SUMMARY/ABSTRACT
B cell memory generated by antigen exposure consists of antibodies and memory B cells (MBCs). The human
spleen is well recognized as a major MBC reservoir, but recent studies suggest that its role goes beyond MBC
storage. There is evidence that MBCs in the spleen receive signals that modify phenotype and function. In
addition, it has been proposed that the spleen serves as an archive of all MBC clones that disperse from sites of
formation via the blood. Our objective is to perform the first antigen-specific evaluation of the spleen as an
evolving MBC archive that represents an individual’s MBC response potential. We will use the influenza A virus
hemagglutinin (HA) as a model antigen, since most adults have a large pool of HA-reactive MBCs modified by
multiple exposures to variant HA strains and often retaining an imprint of early-life infection. We will test
hypotheses about the composition a splenic HA-reactive MBC archive based on our current strong
understanding of HA-specific B cell responses and MBC formation in humans. Experiments will be performed
using a large collection of stored splenocytes from surgically removed trauma spleens.
Under Aim 1, we will test the hypothesis that the size of splenic MBC populations reactive to HA strains and to
the conserved HA stalk domain reflect early-life imprinting. The size of MBC populations will be determined by
in vitro stimulation of splenic MBCs and measurement of secreted HA-reactive antibodies by multiplex binding
assay. Association of HA reactivity with phenotypic MBC subsets will be analyzed by flow cytometry using 29
surface markers and a set of HA probes. Under Aim 2, we will test the hypothesis that an evolving splenic archive
mostly contains large numbers of MBCs that are broadly HA cross-reactive. Individual HA+ MBCs will be index
sorted and stimulated to induce antibody-secreting cell formation. Clonal antibodies in culture supernatants will
be analyzed to determine HA reactivity and affinity. To evaluate the completeness of the splenic archive, Aim 3
studies will test the hypothesis that the archive contains families of clonally-related MBCs with ranges of somatic
hypermutation and reactivities to HA strains recognized only in early life, chronological ranges of HAs that
frequently include early HAs, and sets of contemporary HAs. Splenocyte samples shown under Aim 2 to contain
MBCs with an early-life HA imprinting signature will be selected for multivariate single cell analysis.
Immunoglobulin heavy chain variable gene sequencing, calculation of mutation frequencies, and evolutionary
tree analysis of clonal clusters will be performed and correlated with HA reactivity profiles.
We expect our investigation of the spleen as an archive of HA-reactive MBCs to extend our understanding of the
spleen as a key determinant of an individual’s MBC-mediated immunity. This information is essential for a full
appreciation of the potential consequences of splenectomy, disease states associated with hyposplenism, B cell
depletion therapies, and splenic changes associated with infections.

Public health relevance
PROJECT NARRATIVE Our proposal investigates the concept of the human spleen as an evolving and complex archive of antigen- specific memory B cells (MBCs), rather than simply an MBC reservoir. Findings supporting this idea would suggest that the spleen plays an unappreciated role in MBC maintenance and is potentially a key determinant of an individual’s MBC response potential. Results could be important for a full appreciation of the consequences of splenectomy, disease states associated with hyposplenism, B cell depletion therapies, and splenic changes associated with infections.